Deciphering the cellular origins and impact of toxic formaldehyde in mammalian cells

PROJECT SUMMARY
Formaldehyde is a well-recognized human genotoxin found commonly in the environment but also produced
endogenously in mammalian cells. While environmental exposures to formaldehyde are strictly minimized, recent
work has shown that mammalian cells are exposed to quantities of endogenous formaldehyde sufficient to cause
cancer and pre-mature aging in children with genetic deficiency in formaldehyde-detoxification enzymes or DNA
repair pathways. However, beyond these genetic syndromes, we know very little about the life factors that
determine the level of endogenous formaldehyde and its impact on health within the general population. Although
several biochemical reactions in the cell can generate formaldehyde, such as by demethylase enzymes, and
through spontaneous decomposition of folate, the contribution by these reactions to formaldehyde burden and
toxicity in vivo is not characterized. Therefore, the overall objectives of this R35 proposal are to better understand
the fundamental biology of endogenous formaldehyde production and toxicity in mammalian cells by 1)
identifying the physio-pathological sources of formaldehyde in vivo and define how these pathways can be
dysregulated to elevate formaldehyde burden, and 2) dissecting the different mechanisms by which endogenous
formaldehyde disrupts cell function. To address these objectives, we have developed an innovative and ultra-
sensitive workflow that combines a formaldehyde biosensor with mass spectrometry to detect formaldehyde
production in mammalians cell lines and mouse models under basal homeostasis and stressed metabolic states.
We will leverage this workflow with metabolic and genetic approaches to identify the metabolic conditions and
factors that impact formaldehyde production. In parallel, we have utilized a genome-wide CRISPR screen to
highlight novel formaldehyde-sensitizing genes that could reveal novel mechanisms of mammalian
formaldehyde-toxicity. Successful outcomes from our research will help to build a framework to understand the
key cellular factors that determine endogenous formaldehyde level and the subsequent cellular toxicities that
arise. The knowledge gained and novel research tools generated will form the foundation for future studies into
how endogenous formaldehyde contributes to human diseases and designing interventions that target
formaldehyde to improve health.

Public health relevance
PROJECT NARRATIVE Mammalian cells produce high levels of a reactive toxic chemical called formaldehyde. This proposal sets out to identify the health-relevant life factors that trigger endogenous formaldehyde production and characterize how excess cellular formaldehyde can damage cell function.